Shared Resource Management

Abstract Shared Resource Management
The COHCCC Shared Resources play a vital role in support of the cancer-focused research of all five programs
within the CC, spanning the translational pipeline from the earliest phase of discovery to the manufacture of new
biologics, cell therapeutics, and small molecules for preclinical and Phase 1 studies.
Specific Aims for SRM:
Aim 1. Provide centralized SR leadership and oversight to meet the scientific needs of COHCCC
Members.
Aim 2. Implement effective, standardized policies and practices that govern the use and evaluation of
SRs.
Aim 3. Respond to the current and future scientific needs of COHCCC Members via targeted
enhancements to SR infrastructure, services, and operations.
The Shared Resources management structure oversees all operational aspects including equipment acquisition
and maintenance, billing, staffing, informational seminars, and consistent monitoring of service quality and
operational efficiency. This is accomplished via cooperative interactions between the SR Directors, their
respective Advisory Committees (SRAC), the Shared Resources Steering Committee (SRSC), Shared
Resources Administration (SRA), and the AD for Shared Resources. User feedback is provided from multiple
inputs, through formal and informal mechanisms, and provides the basis for continual surveying of all aspects of
COHCCC SR operations. Changes in service lines, SR leadership, and addition of new SRs are finalized under
the direction of the COHCCC Director and COHCCC EC working in conjunction with the AD, SRSC, and SRM
with the goal of constant improvement. Since the last review, significant changes have included complete
integration of SRs between COH and TGen, enhancement of high throughput screening and digital imaging
services, inclusion of mathematical oncology under biostatistics (BMOC), and significant upgrades in services
and leadership structure for both Integrated Mass Spectrometry (IMS) and Research Pathology (RP). A Clinical
Microbiome (CMB) SR is proposed as a new CCSG resource to enhance collaborative interactions between
COH and TGen CCC faculty, and complement existing SRs in support of the strategic goals of the cancer center.
Aggregate of all CCSG Cores:
Members Utilization by %Revenue 2017–21: 92.7 Total (14.5 MCBC, 13 DCT, 26.5 CI, 32.1 HM, 6.6 CCPS,)
Publications by Members: 637, 180 with Impact Factor >10
Grants Supported: 303 Total (7 ACS, 17 CIRM, 19 DoD, 7 LLS, 139 NCI of 226 NIH (1 P01, 145 R01, 12 U01))